Implementation of Coordinated Spontaneous Awakening and Breathing Trials Using Telehealth-Enabled, Real-Time Audit and Feedback for Clinician AdHerence: A Type II Hybrid Effectiveness-Implementation

PROJECT SUMMARY
Although invasive mechanical ventilation (IMV) is a lifesaving treatment for about 300,000 U.S. patients with
acute respiratory failure each year, it is associated with significant risks. Spontaneous awakening and
breathing trials during IMV improve patient outcomes. Coordination of spontaneous awakening and breathing
trials (C-SAT/SBT) is complex and significant barriers to implementation exist and adherence with C-SAT/SBT
across institutions is highly variable. Although national guidelines recommend daily coordinated C-SAT/SBT in
IMV patients they are underused.
Telehealth-enabled remote care is positioned to improve C-SAT/SBT use. At Intermountain Healthcare, we
have system-wide tele-critical care services staffed by critical care physicians, nurses, and respiratory
therapists who remotely monitor and assist with patients in ICUs using real-time audiovisual communication, a
systemwide electronic medical record (EMR), electronic dashboards, and clinical decision support. We
recently studied the impact of implementation strategies to improve evidence-based practices for lung
protective ventilation (LPV) in 3 pilot ICUs, and then adopted a Telehealth-Enabled, real-time Audit and
feedback for Clinician adHerence (“TEACH”) to disseminate LPV adherence strategies to the other 14 ICUs,
achieving over 90% adherence (NCT 03984175). This successful approach could help identify candidates for
C-SAT/SBT protocols, prompt bedside providers to perform C-SAT/SBT, and guide execution.
The specific aims of this research are to (1) adapt baseline implementation strategies and to target C-
SAST/SBT using the Consolidated Framework for Implementation Research; (2) conduct a type II cluster-
randomized hybrid effectiveness-implementation trial to compare a usual audit and feedback implementation
approach to a usual audit and feedback implementation approach augmented with a Telehealth-Enabled, real-
time Audit and feedback for Clinician adHerence (“TEACH”) to promote C-SAT/SBT; and (3) evaluate
sustained adherence to the TEACH enhancement in the final year after the RCT has ended.
Completion of this project will advance knowledge regarding the effective and sustainable strategies for C-
SAT/SBT implementation specifically and the effectiveness generally of telehealth remote monitoring and
prompting strategies to aid best practice implementation in ICUs. The proposed research builds on the study
team’s existing work and has potential to develop more informed and effective care of persons with respiratory
failure. Spread and scale of this telehealth-enabled, central monitoring of critical aspects of care for ICU
patients is particularly important to study now, given the vulnerability of ICU staff to COVID-19 exposure.

Public health relevance
PROJECT NARRATIVE Approaches to prolonged invasive mechanical ventilation (IMV), including management of sedation and movement, for patients with respiratory failure may lead to delirium, slower recovery, and poor long term cognitive outcomes. Coordinated spontaneous awakening and breathing trials (C-SAT/SBT) have been shown to improve these outcomes but are underutilized. The goal of this proposal is to use the Consolidated Framework for Implementation Research to understand the barriers and facilitators to implementing strategies for C-SAT/SBT in IMV patients, by evaluating the impact of a Telehealth-Enabled, real-time Audit and feedback for Clinician adHerence (“TEACH”) implementation strategy, to achieve high adherence and measure the impact on ventilator-free days, in a cluster randomized trial.